Bioengineering probiotic bacterium contrast agents for monitoring of inflammation using multispectral optoacoustic tomography

PROJECT SUMMARY
Inflammatory diseases include a vast array of disorders including, arthritis, autoimmune diseases, hepatitis, and
inflammatory bowel disease (IBD) among others. The ability to image inflammation in vivo is critical to improve
the understanding of the pathophysiology underlying various disease etiologies. Current technologies to image
IBD suffer from using radiation, lack of specificity, high cost, or invasive procedures that carry risk from both
sedation or anesthesia and colonic perforation. Therefore, there is an urgent need to develop a noninvasive
imaging modality that accurately identify early inflammatory changes, that can be used longitudinally to monitor
the status of disease. With the use of a newly emerging imaging technology, multispectral optoacoustic
tomography (MSOT), MSOT has potential for detecting inflammation and has the capability to detect multiple
contrast agents simultaneously. The development of contrast agents detectable for this modality has largely
explored nanomaterials, dye-labeled peptides, or dye-labeled antibodies. Although synthetic contrast agents for
molecular imaging have shown great efficacy on disease diagnosis in preclinical trials, many of these synthetic
agents have limitations such as low biocompatibility, material-associated toxicity, poor clearance, and high cost
of pilot scale production. To overcome these limitations, the objective is to develop the first probiotic bacterial-
based contrast agent to monitor inflammation using MSOT.
Probiotics comprise primarily lactic acid bacteria, Lactococcus lactis (L. lactis) and are designated as generally
regarded as safe organisms by FDA. L. lactis is well established as an efficient expression system for
recombinant proteins and is being intensively investigated for delivery of antigens and cytokines at the mucosal
level. It was demonstrated that the blue color generated from L. lactis-Blue (LlB) is detectable by MSOT. The
goal is to bioengineer a stimuli-responsive L. lactis-Blue and dual label it with Zn-DPA-CF750 to result in a
bacteria-based dual labeled contrast agent to monitor inflammation, using colitis as an inflammatory model, by
MSOT. The hypothesis is that endogenous hemoglobin alone with MSOT will be insufficient to monitor chronic
inflammatory diseases, thus, the proposed single or dual bacterial-based contrast agent, will target inflammation
and provide additional molecular information to facilitate monitoring of inflammatory diseases. This hypothesis
will be tested as follow: 1) Engineer and characterize LIB as a biologically-based contrast detectable using
MSOT, 2) Construct and characterize L. lactis-750 and LIB-750 as single and dual bacterial-based contrast
agents detectable using MSOT, and 3) Determine the potential of LIB, L-750, and LIB-750 as biological contrast
agents to identify areas of inflammation using MSOT in a mouse model of colitis. Collectively, this proposal
represents one of the first developments of a bacterial-based optoacoustic detectable contrast agent to further
enhance the detection of inflammation associated with colitis.

Public health relevance
PROJECT NARRATIVE Multispectral optoacoustic tomography (MSOT) is a non-invasive newly emerging imaging technology that potential for detecting inflammation. MSOT can identify areas of inflammation, but additional molecular information is often required, particularly in areas of chronic inflammation, which can be enhanced by probiotic bacterial-based contrast agent.